Emotions and Choice: Mechanisms of Behavior Change

Project Summary The goal of the proposed research is to understand and develop successful means of behavior change that could assist in treatment compliance broadly for a range of health problems, as well as specific treatments for disorders characterized by poor choices, such as obesity and addiction. To achieve this goal, we will combine techniques and insights from neuroeconomics and affective neuroscience. Specifically, we will use behavioral economic paradigms and models to isolate and quantify specific individual factors that influence decisions, including the rate at which future rewards are discounted in value and the relative sensitivity to loss or risk when assessing value. We will link these specific decision variables to specific components of emotion that may contribute to the value computation, such as the arousal response to a loss or gain. We will then build on recent advances in affective neuroscience examining means to change emotion -- including cognitive emotion regulation techniques and pharmacological manipulations - to explore how these impact the different decision variables. Finally, we will examine how another common emotional response known to impact health decisions, namely stress, alters both the specific decision variables and the effectiveness of the proposed techniques used to alter emotional responses and choice behavior.

Public health relevance
Project Narrative It is not uncommon for individuals to make decisions that can be detrimental to their health and well-being, such as in obesity and addiction. The proposed research will combine insights from the science of decision making and emotion to develop new means to encourage behavior change. __SpecificAimsTextDelimiter__ Specific Aims Classic economic models assume that choices are the result of a rational analysis of the options, but an examination of human behavior reveals clear bounds to this rationality. Humans routinely make non-optimal choices -- from underestimating the health and social consequences of ignoring treatment recommendations to choosing what to eat or whether to take drugs. These types of non-optimal decisions play a substantial role in driving everyday behaviors in normal populations and are exaggerated in clinical populations. The goal addressed in this proposal is to understand and develop successful means of behavior change that could assist in treatment compliance more broadly, as well specific treatments for disorders characterized by poor choices, such as obesity and addiction. To achieve this goal we will combine techniques and insights from neuroeconomics and affective neuroscience to both understand and alter the mechanisms underlying decisions for action. Although there has been extensive psychophysical and neuroscience research characterizing the representation of simple perceptual decisions (Sugrue et al., 2005), and behavioral and neuroeconomics research examining economic decisions (Glimcher et al., 2008), this research has rarely been extended to changing decisions for action. A primary reason is that changing decisions not only requires understanding the process underlying the decision, but also the motivational factor driving the decision, which is the representation of value. If we can't influence the reason the decision is made, we can't utilize this knowledge to change behavior, even if we develop a perfect characterization of the decision process. Economists often describe value as an abstract property of objects and events that is relatively stable. Accordingly, economists view the representation of value as somehow distinct from emotion (Kahneman, 2003). However, affective scientists have a different approach. Theories of emotion suggest a primary function of emotion is to highlight the relevance of stimuli and events in order to guide adaptive behavior (Fridja, 2007). In this view, emotion is a key component of the representation of value. Although the proposed research will adopt the theoretical tools of neuroeconomics, it assumes the affective neuroscience view of value. That is, the computation of value incorporates aspects of the emotional response. This tight link between emotion and behavior suggests a potential avenue for changing behavior -- by changing emotion. By combining approaches and techniques across disciplines we propose to provide insight into how different aspects of emotion might be linked to specific components of the decision process, and to explore how techniques for changing emotion might alter choices. Adopting paradigms and models from behavioral economics, we will quantify within individuals three decision variables that predict choice: 1) loss aversion, or the tendency to weigh losses more than gains, 2) risk sensitivity, and 3) temporal discount rate, which captures the tendency to discount future rewards in favor of short term gains. For each decision variable, we will examine the relation to emotional responses and explore how changing the emotional response alters the choice. Finally, we will explore the neural systems mediating the relation between decisions and emotion to provide insight into how emotion, and its alteration, changes the neural representation of value and choice. There are three specific aims: Aim 1: To establish a link between variability in loss aversion, risk sensitivity, and temporal discounting and the emotional response to components of the decision process. The component of the emotional response assessed will be physiological arousal. Aim 2: To examine the impact of altering the arousal response on the indentified decision variables. Two techniques will be used to alter arousal: cognitive emotion regulation and pharmacological blockade. Aim 3: To explore the impact of a stress manipulation resulting in elevated cortisol on the specific decision variables and the effectiveness of the proposed techniques used to alter emotion and choices. For each aim, we will use fMRI to explore the neural systems mediating the relation between emotion and decisions. We expect the interaction of the amygdala and striatum to play a role in the impact of emotion on the representation of value and choice. In addition, we expect the prefrontal cortex to be involved in the cognitive regulation of emotion and choice and to be specifically impacted by the stress manipulation, resulting in diminished effectiveness of these techniques under stress.